NEUROLOGIC ONCOLOGY

The Neurologic Oncology Program comprises 22 members, drawn from 9 different departments, representing fundamental laboratory research in the origins and molecular basis of brain tumors, neurooncologists, radiologists and neurosurgeons who take a team approach to the improvement of brain cancer therapy, and population scientists working on brain cancer epidemiology. Research goals include understanding how brain cancers relate to neural stem cells, the relationship between brain tumors and their stromal environment and their vasculature, and a better understanding of altered signaling pathways. These new insights are being translated into improved therapies for patients suffering from brain cancer, along with innovative methods of detecting tumors and of drug delivery. This group of investigators is both highly productive and interactive. Their publications include works published in Nature, Cancer Cell, Nature Cell Biology, Nature Genetics, New England Journal of Medicine, Journal of Clinical Oncology, and Nature Medicine. The broad range of publications covering population science, cell signaling, genomics, imaging, and clinical science, as well as the high percentage of intra- and inter-programmatic publications, are the result of a strategically integrated, highly interactive, diverse, and productive Program that continues to make significant progress in reaching its stated goals. The Program has $8,795,681 Total peer reviewed support for the last budget year. The Program has 33% intra-programmatic and 38% inter-programmatic publications.